Inhibiting sequential biosynthetic steps of a fungal-specific organelle

PROJECT SUMMARY/ABSTRACT
Candida albicans is the most frequently isolated fungus causing invasive disease in the United States.
These infections are dreaded complications of serious illnesses, especially in hospitalized or
immunocompromised patients. C. albicans infections are challenging to eradicate, and are still estimated
to lead to death in 20% of the affected patients. Currently only 3 classes of antifungal drugs are available
to treat invasive fungal infections. Antifungal drug development is difficult because of the similarity between
fungal and human cells, which leads to unacceptable toxicity of many compounds that damage or kill fungi.
Developing antifungal agents whose targets are absent in human cells would circumvent this difficulty.
Increasing potency of antifungal drugs could also lead to better outcomes. A paradigm for increased
antimicrobial potency is the important combination antibiotic Cotrimoxazole, whose two components target
sequential steps in the biosynthesis of tetrahydrofolate.
The goal of this proposal is to find compounds that can be developed into specific inhibitors of two
cellular processes unique to fungi, whose combination could give rise to a more potent antifungal agent.
Two fungal cellular processes that are fundamentally different or absent in humans are phosphate
homeostasis and cell wall construction. We previously found that the major C. albicans high-affinity
phosphate transporter Pho84 is required for normal nutritional (Target of Rapamycin-) signaling, cell wall
stress- and oxidative stress resistance, hyphal growth and virulence. Since humans manage their
phosphate balance completely differently from fungi, blocking Pho84 is not predicted to impact human
cellular functions. Pho84 is highly conserved across the fungal kingdom, including in emerging pathogens
like Candida auris. Cells that lack Pho84 contain diminished concentrations of nucleotides, whose
production requires ample intracellular phosphate supplies, and of their downstream metabolites,
nucleotide sugars. Nucleotide sugars are precursors for biosynthesis of the major cell wall polymers. We
propose to take advantage of this defect to sequentially perturb major steps in cell wall biosynthesis by
combining inhibition of Pho84 with inhibition of glucan biosynthesis. To do this, we established a novel
high-throughput assay system to detect specific inhibitors of these fungal targets. We will prioritize hit
compounds according to their biological effects in virulence-associated or essential cellular processes, and
according to their chemical features. This work will lay the ground to apply the paradigm of stepwise
inhibition of a critical biosynthetic process to antifungal drug development. The proposal is intended to
select screen hits that meet defined biological and medicinal chemistry criteria for further development.

Public health relevance
NARRATIVE Treatment options for invasive candidiasis, the most common of deadly fungal infections, remain limited. We propose to use the example of an important antibiotic, to develop a novel antifungal medication that targets sequential steps in construction of the fungal cell wall. In the process, we will establish a novel screening approach that can increase selectivity for fungal drug targets that are absent in humans, in order to minimize toxicity while optimizing potency.